Administrative supplement

Abstract
Down syndrome (DS) is associated with an elevated likelihood of co-occurring neurodevelopmental conditions,
including autism spectrum disorder (ASD). Although dimensions like sleep and brain activity are considered
critical areas of interest in the investigation of nonsyndromic ASD, these physiological dimensions have not been
characterized to date in co-occurring DS and ASD. This Administrative Supplement will expand the scope of
R01HD110542 (Autism in Young Children with Down Syndrome) to evaluate the feasibility of collecting
physiological measures of sleep and neural function in young children with DS, and their potential association
with autism-related features. We will leverage the ASD-related phenotyping data collected in the parent R01 and
collect both sleep actigraphy and fNIRS data concurrently with ASD assessment visits for 50 participants in
R01HD110542 Project Year 2. We will collect child actigraph data across seven continuous days and nights and
calculate sleep duration (sum of nighttime and daytime sleep episodes), timing (sleep start and end time),
consolidation (ratio of daytime sleep duration/nighttime sleep duration), and fragmentation (number and
duration of nighttime awakenings). Caregivers will also complete a standard daily sleep diary and sleep
questionnaire to assess contextual factors impacting child sleep environment. Brain activity will be measured
during the study visit via fNIRS. We will evaluate the feasibility of collecting usable data from these measures in
children with young children with DS and subsequently analyze how physiological dimensions are associated
with early social communication and play, two dimensions relevant for early ASD detection. Results may
facilitate the discovery of additional indicators of ASD risk in DS, and potentially identify mechanisms that
contribute to the onset of ASD in DS in ways that can inform future treatments in this population.

Public health relevance
Narrative This aim of this Administrative Supplement project is to evaluate the utility of sleep and brain activity data to advance the early detection of autism spectrum disorder (ASD) in young children with Down syndrome (DS). We will leverage ASD-related phenotyping data collected in R01HD110542 and collect sleep actigraphy and fNIRS data concurrently with ASD assessment visits. Evaluating the feasibility of collecting usable data from these measures, and the subsequent use of these measures when feasible, may advance the early detection of co- occurring DS and ASD, identify potential mechanisms that contribute to the onset of ASD in DS, and potentially contribute to the development of novel interventions.